Research Initiative for Scientific Enhancement Option II at Jackson State University

? DESCRIPTION (provided by applicant): Jackson State University (JSU) is committed to increasing the number of Underrepresented Minority Students participating in the field of Biomedical Research. The historical mission of the university has been to foster an environment dedicated to student achievement in populations that have traditionally been underserved. JSU believes that in order for any student to achieve success in biomedical research careers, a student must learn foundational skills (reading, writing, speaking, listening, and numeracy), develop critical thinking skills, and master analytical inquiry (metacognition and ethical development). This proposal attempts to intentionally develop these skills through the RISE-S.T.E.P.S. program. This proposed program contains three program components; Curriculum Enrichment, Biomedical Research Enhancement, and Interpersonal Development and Social Integration. This proposal will combine best practices found within the university in other disciplines, current literature, and accepted mentoring approaches to increase the number of students that not only desire to become biomedical researcher, but have the tools to be leaders in their respective fields.

Public health relevance
PUBLIC HEALTH RELEVANCE: A number of universities struggle to attract and identify URM students to participate and complete a biomedical pipeline. JSU, however, has a significant number of URM students that are interested in such programs. JSU, however, realizes that a number of students that attend JSU come from traditionally underserved areas resulting in a lack of preparation for college. This deficiency often causes interested students to struggle with coursework, rigorous programs, and enriched training. This often concludes in higher turnover and a higher dropout rate. JSU has in the past three years focused on minimizing the detrimental impact a student's background has on his/her college development. The University has identified three areas that it believes every student at JSU must have in order to be successful at JSU. These three areas have been the focus of JSU programs, faculty, and staff to endure greater inclusion in general studies. We propose that each of these must also be included in a biomedical program to ensure intentional student development and combat major changes and dropouts due to academic struggles.